Cytoplasmic chromatin fragments in cell senescence - novel mechanisms and interventions

PROJECT SUMMARY
Cellular senescence is a cause of cell and tissue aging. Senescence is caused by a range of cellular stresses
and characterized by an irreversible proliferation arrest and a potent pro-inflammatory phenotype, the
senescence-associated secretory phenotype (SASP). Senescence-associated proliferation arrest and SASP
cooperate in tumor suppression, by arresting proliferation of damaged pre-malignant cells and promoting
immune clearance of the damaged cells. However, over the longer term, as a source of chronic inflammation,
SASP also promotes tissue aging and disease. Consequently, there is currently much effort devoted to
development of pharmacologic approaches to eliminate senescent cells to promote healthy aging. However,
these so-called senolytic drugs tend to show unwanted toxicities. An alternative, perhaps less toxic approach, is
to use senomorphic drugs to specifically inhibit the pro-aging SASP. Importantly, inhibition of SASP does not
necessarily impair the tumor suppressive role of senescence. On the contrary, elimination of SASP can prevent
cancer. Hence, it is important to define the mechanism of SASP activation, because its inhibition may be an
approach to combat the pro-aging effects of senescent cells.
Recently, we showed that senescent cells shed fragments of nuclear chromatin into the cytoplasm, cytoplasmic
chromatin fragments (CCF), via a nucleus-to-cytoplasmic blebbing process. CCF are very strongly positive for a
DNA damage marker, phosphorylated histone γH2AX. Formation of CCF depends upon a novel manifestation
of the cellular recycling process autophagy, specifically nuclear autophagy. CCF signal through cytoplasmic DNA
sensors to activate NFκB, the major transcriptional activator of SASP. Most recently, we have defined an
unanticipated upstream trigger of CCF and SASP, namely dysfunctional mitochondria in senescent cells.
Dysfunctional mitochondria are themselves already linked to chronic inflammation and aging.
We hypothesize that nuclear expulsion of CCF harboring DNA double strand breaks is a mechanism for
senescent cells with impaired DNA repair pathways to decrease the intranuclear load of toxic DNA double strand
breaks. We also hypothesize that dysfunctional mitochondria trigger autophagy-dependent formation of CCF in
senescent cells by retrograde mitochondria-to-nucleus signaling, involving JNK kinase and the transcription
factors Hypoxia Inducible Factor 1a (HIF1a), the “JNK-CCF” and “HIF-CCF” pathways, respectively.
Delineation of the JNK-CCF and HIF-CCF pathways and their interactions will provide new opportunities to
intervene to suppress chronic inflammation driven by SASP in vivo, thereby potentiating healthy aging and
longevity.

Public health relevance
PROJECT NARRATIVE Tissue aging and disease is caused, in part, by accumulation of pro-inflammatory senescent cells in aged tissues. We will define novel molecular mechanisms responsible for this inflammatory phenotype and test novel interventions for their ability to suppress this proinflammatory pathway. This can provide new targets and strategies for interventions in humans to promote healthy aging and longevity.